Pathology Core

Core D – Pathology Core
Director – David K. Meyerholz
PROJECT SUMMARY
The Pathology Core will provide professional services and expertise to Investigators of the
Program Project. The Pathology Core will provide: 1. Technical expertise, labor and services for
histotechnology applications from fixing tissues, processing, embedding,
sectioning/cryosectioning, and performing routine to specialized histochemical and
immunohistochemical stains for high quality tissue data. 2. Pathology expertise through a
veterinary pathologist experienced with CF tissues including those from humans and animal
models (pig and ferret). Pathology Core personnel will provide specialized support and
consultation for examination, interpretation and scoring of tissue changes for Program
Investigators. 3. increased efficiency for Program Project Investigator Labs through devoted
effort of professional staff and centralized availability of specialized techniques and reagents,
including those that are time sensitive. This will produce significant savings in cost, labor and
time. Program Project Investigators will have full access to the Pathology Core's professional
expertise and resources, and Core personnel will provide services to Investigators in a timely
and efficient manner.